Predoctoral Training in Cross-disciplinary Molecular and Cellular Biology

Project Summary/Abstract
The goals of this training program entitled “Predoctoral Training in Cross-disciplinary Molecular and Cellular
Biology” (CMCB) at Brandeis University are to produce rigorous, quantitative scientists with expertise in multiple
disciplines, to provide trainees with the skills needed to succeed in diverse science-related careers, and to help
trainees explore and pursue their career interests in an informed manner. This new program combines the
complementary strengths of two prior Brandeis T32 programs: “Genetic and Biochemical Mechanisms of
Regulation, T32GM007122”, expiring after >40 years of NIGMS support, and “Quantitative Biology,
T32EB009419”, expiring after 10 years of NIBIB support. While both training programs had strong track
records of student research productivity and career outcomes, we significantly rethought and revised core
elements of training (based on student and faculty feedback) to better prepare students for a future in which
interdisciplinary research is increasingly crucial. Innovations include: (1) increased quantitative training,
through courses and an annual workshop, (2) revising the timing and goal of the qualifying exam, both to
improve the training value and to better serve students from diverse scientific and personal backgrounds, (3)
earlier implementation of Individual Development Plans and Thesis Committee Meetings to accelerate trainee
career development and research progress, (4) introducing a secondary research advisor in a complementary
discipline to facilitate interdisciplinary training, (5) a two week professional Externship in Year 4+, (6) new
program self-assessment mechanisms, including semi-annual trainee feedback and the creation of an External
Advisory Committee, and (7) formal training in and oversight of mentoring for all training faculty. Trainee
appointments will be made at the end of Year 1, after students have completed one year of coursework, four 9-
week laboratory rotations, and chosen a lab. In Year 2, trainees serve as teaching assistants for one course per
semester, take a Proseminar course to help them craft their thesis research plan and defend it at their qualifying
exam (end of Year 2), and to develop a career Individual Development Plan (IDP). In Year 3+, trainees take a
final elective and focus on their research. They present their work at annual Departmental talks, have annual
Thesis Committee Meetings focused on career planning and research progress. In Year 4+, they engage in a
two-week career Externship and serve as mentors at the annual Quantitative Analysis workshop. Program
outcomes and success will be measured by: (1) sustained research impact (reflected in trainee publications),
(2) development of independent scientific thinking and communication (assessed through thesis proposals,
annual Departmental talks and Thesis Committee Meetings), (3) active trainee engagement in their own career
development (reflected in annual IDPs, discussions at Thesis Committee Meetings, and the new Externship
program), and (4) trainee placement and long-term success in science-related careers. There are 29 CMCB
training faculty, and 12 slots are requested (~6 trainees/year, with trainees supported in Years 2 and 3).

Public health relevance
Project Narrative The goal of this new graduate student training program is to produce rigorous, quantitatively-minded scientists equipped to solve increasingly complex problems in Molecular and Cellular Biology using integrated, cross-disciplinary approaches. In addition to rigorous coursework and research training, students are provided with layered, individualized career development activities to help prepare for diverse scientific research and other science-related careers.